Integrating Climate Impacts into a Community Health Assessment for Rural Communities

PROJECT SUMMARY
The science is overwhelming that our planet is changing, and these climatic changes are exerting
catastrophic pressures on local communities, with little time to reverse course. In the US, climatic variability
and associated changes in weather patterns are creating new health risks and exacerbating existing health
disparities in overburdened communities across the Nation. Local health departments and health care systems
are front line defenders of the population’s health and play a key role in a community’s resilience to climate
change. Yet climate-related health threats are not currently prioritized in local or regional community health
assessment efforts, particularly in rural areas like Southern Appalachia. Partnerships between hospital, public
health, community members, and environmental health scientists are often underutilized channels in examining
the health impact of climate change as an environmental determinant that works independently and jointly with
other social determinants to amplify local health risks. The overarching goal of this community-driven
project is to integrate climate change impacts into a regional health assessment framework to enhance
the capacity of local public health systems to protect the health of rural communities. We will achieve
the following specific aims: Aim 1. Integrate climate change data into the regional community health
assessment and examine climate sensitivities in priority health concerns; Aim 2. Engage regional hospitals,
public health departments, and community members in the co-design of visual storytelling of local climate and
health priorities; and Aim 3. Co-design targeted communication messaging to advance awareness on regional
climate impacts on health. Our expected outcomes will include the: (1) integration of climate data into a
regional community health assessment planning process; (2) identification intrinsic rural community health
networks that will inspire commitment and foster capacity for community-wide participation in present and
future climate resilience planning; and (3) targeted communication trainings and public health messaging to
advance awareness on current and future climate impacts in the region. This work has the potential to be
transformative to the field by providing a public health model for integrating climate change impacts in a
regional community health assessment process for rural and historically marginalized communities. The long-
term goal is to advance a national model that demonstrates the identification, prioritization, and implementation
strategies to help communities address climate change impacts on health. This project will leverage WNC
Health Impact, a partnership and coordinated process in existence for over a decade, to engage hospitals,
public health agencies, and key regional partners in a 16-county region in rural Appalachia around a vision of
improved community health. Results will address a well-cited research need from the NIH Climate Change and
Health Strategic plan to identify and develop local and regional interventions to monitor and reduce the
adverse health effects of climate change in rural populations.

Public health relevance
PROJECT NARRATIVE The science is overwhelming that the climate of our planet is changing with little time to reverse course and climate action has the potential to benefit human health and address long standing health inequities; yet local health departments and health care systems—frontline defenders of the population’s health—have historically not engaged in local climate resilience efforts. Local health systems are in constant recovery mode as evidenced by the significant impact of the COVID-19 pandemic and critical barriers to local climate action include a lack of expertise, capacity, and sustained funding within the public health workforce. The proposed community-driven project seeks to integrate climate change impacts into a regional community health assessment framework to enhance the capacity of local health systems to identify, address, and monitor climate impacts on health in rural Appalachia.